Special Projects-Sample Collection

PROJECT SUMMARY / ABSTRACT The Minnesota Department of Agriculture (MDA) Laboratory Services Division (LSD) is seeking funding under FDA funding opportunity PAR-20-105, “Laboratory Flexible Funding Model (U19)”. This summary is for the Special Projects: Sample Collection Track. The purpose of this track is to assist laboratories in obtaining the samples needed to meet the goals of the cooperative agreement. The MDA laboratory has committed to analyzing 600 Human Food and 750 Animal Food samples. The MDA Food and Feed Safety Division has agreed to collect at least 15% samples for the laboratory. The rest of the samples will be collected by MDA Laboratory personnel. Project Summary/Abstract - Minnesota Department of Agriculture